Critical Care Training Program

This renewal submission for an institutional training grant is aimed at providing research training for
postdoctoral trainees who will pursue careers related to critical care. The training program will be jointly based
in the Emory Critical Care Center and in the Department of Surgery at Emory University School of Medicine. It
will be multidisciplinary in nature, with faculty in the Departments of Surgery, Medicine, Pediatrics, Biomedical
Informatics, Anesthesiology, Microbiology and Immunology, Biochemistry and Biomedical Engineering
participating in the training program. The training program is two years of length, and all applicants must have
a graduate level degree (MD, PhD or equivalent). The goal of this training program is to provide cutting-edge
training in critical care research founded upon strong collaborations among clinicians and investigators. The
program director/principal investigator is Craig Coopersmith, Professor of Surgery at Emory University and the
Interim Director of the Emory Critical Care Center. The PI/PD will interface closely with an executive committee
made up of Timothy Buchman, MD, PhD (Professor of Surgery, Emeritus Director Emory Critical Care Center),
Greg Martin, MD (Professor of Medicine, Director of Research, Emory Critical Care Center), Mandy Ford, PhD
(Professor of Surgery), and Jonathan Sevransky, MD (Professor of Medicine) The program has 16 additional
mentors with widely varying research interests in domains related to critical care ranging from oxidative stress
to metabolomics to big data to predictive analytics in the intensive care unit. The program allows trainees to
choose either a traditional laboratory-based track or a clinical track where they will also obtain either a Master
of Science in Clinical Research or a Masters of Analytics. There are opportunities that span the entire age
range of critical illness – from neonates to geriatrics. To provide a diverse set of opportunities, mentors are
based at the following-types of hospitals in the Atlanta area within a 5 mile radius – academic (Emory
University Hospital), public/safety-net (Grady Memorial Hospital), community (Emory University Hospital
Midtown), federally-funded (Atlanta Veterans Affairs Medical Center), and pediatrics (Children's Healthcare of
Atlanta Egleston Hospital). Ultimately, the research-training program is designed to reflect the collaborative
and interdisciplinary nature of clinical critical care and to develop independent researchers dedicated to
improving the outcomes of patients in the intensive care unit.

Public health relevance
As the population ages, more and more patients are cared for in intensive care units. However, there is a growing gap between the rapidly expanding need for critical care services and both the workforce needed to take care of critically ill patients and the researchers needed to discover new insights to improve outcomes in the intensive care unit. This institutional training grant is aimed at bridging this gap by providing research training for individuals who will pursue careers related to critical care.